Molecular mechanisms of splicing dependency in cohesin-mutant myelodysplasia

Project Summary
There is a fundamental gap in our understanding of how mutations in the cohesin complex, a multimeric protein
complex essential for sister chromatid cohesion, chromatin organization into loops and gene regulation, cause
myelodysplastic syndromes (MDS). Continued existence of this gap represents an important problem because
despite the high frequency of cohesin mutations in MDS and its association with high risk of disease and poor
outcomes, there are currently no treatment strategies to specifically target cohesin-mutant cells in MDS. STAG2
mutations are mutually exclusive with mutations in the splicing factor SF3B1, the most commonly mutated gene
in MDS. Furthermore, cohesin proteins have been shown to bind SF3 splicing factors and RNA binding proteins
(RBPs) and are dependent on normal spliceosome function for their survival. New genetically engineered models
of cohesin-mutant MDS offer a unique opportunity to test the contribution of disease alleles to splicing
abnormalities and therapeutic response, and to dissect the interaction between the cohesin and splicing
complexes. The long-term goal is to improve outcomes in cohesin-mutant MDS by deeper mechanistic
understanding of disease biology. The overall objective of this application is to determine why splicing is a genetic
dependency in cohesin-mutant MDS. The central hypothesis is that an RNA-mediated interaction between
cohesin and splicing complexes is disrupted in cohesin-mutant MDS and leads to splicing deregulation and
dependency of cohesin-mutant cells on proper splicing, which can be exploited therapeutically. Guided by strong
preliminary data from the applicant’s laboratory, the hypothesis will be tested by pursuing two specific aims: 1)
Determine the splicing changes and the effect of splicing modulation on STAG2-mutant MDS; and 2) Dissect the
interaction between the cohesin complex and the SF3B splicing complex. Under the first Aim, the applicant will
characterize transcriptional and splicing changes in hematopoietic stem and progenitor cells of a novel genetic
murine model of progression from Tet2-mutant clonal hematopoiesis of indeterminate potential (CHIP) to
Tet2/Stag2-mutant MDS. They will also test the effect of splicing modulation on MDS progression in vivo and
using cohesin-mutant MDS patient samples. Under the second Aim, a combination of transcriptomic and cross-
linking and immunoprecipitation experiments will be used in several well established in vitro models to identify
specific RNA species that mediate the interaction between the cohesin and splicing complexes. The approach
is innovative through the application of novel murine models. The downstream effects of the interaction between
cohesin and splicing and its disruption in cohesin-mutant MDS have not been clarified, and the mechanisms
driving splicing dependency in cohesin-mutant cells are unknown. The proposed research is significant, because
it is expected to define the biological role of cohesin mutations in a high-risk subset of MDS associated with poor
outcomes. The expected output for the proposed research is that the knowledge gained will be immediately
clinically significant for patients with cohesin-mutant MDS and inform new treatment strategies.

Public health relevance
Project Narrative The proposed research is relevant to public health because cohesin-mutant MDS is an aggressive disease with poor outcomes, for which there is no targeted therapy available and the mechanisms of which are not well understood. This project is relevant to the NIH’s mission to gain fundamental knowledge to reduce illness because it will elucidate novel treatment strategies in cohesin-mutant MDS based on understanding of the genetic basis of the disease.